Molecular basis of cell-cycle plasticity and robustness

Project Summary
The mammalian cell cycle is commonly conceived as a well-understood, hardwired,
invariant pathway. Emerging work, however, indicates that the cell cycle is much more plastic
than generally believed, with multiple adaptive routes through the cell cycle under different
conditions. This plasticity makes the cell cycle robust to environmental perturbations, but also
drives adaptive drug resistance to targeted cell-cycle inhibitors. A fresh look at the dynamics and
pliability of cell-cycle progression will reveal new principles that predict dependence on a
particular cell-cycle node and new strategies to suppress adaptive cell-cycle rewiring.
Cyclin-Dependent Kinases (CDKs) are key enzymes that drive cell proliferation, and
consequently, multiple CDK inhibitors are in development to suppress unwanted cell proliferation.
However, cells eventually find a way around these drugs to resume proliferation. A plausible
hypothesis is that cells leverage cell-cycle plasticity to pursue alternative paths through the cell
cycle. In one striking example, inhibition of CDK2 leads to rapid loss of substrate phosphorylation
as expected, but then CDK2 substrate phosphorylation rebounds within several hours. This
rebound depends on CDK4 and CDK6, which insulate the cell from fluctuations in CDK2 activity
by maintaining Rb hyper-phosphorylation and E2F transcription. This enables CDK2 re-activation
and eventual cell-cycle completion, even in the presence of potent CDK2 inhibitors.
My lab has pioneered the development of a set of powerful time-lapse microscopy tools
to visualize rapid drug responses in single, living cells. Here, we will apply our technology to
determine the mechanisms driving this unusual rebound in CDK2 activity observed upon CDK2
inhibition. First, we will test the role of the p16 CDK4/6 inhibitor protein on the CDK2 activity
rebound. Second, we will test whether CDK2-dependent degradation of Cyclin D modulates the
CDK2 activity rebound. Third, we will identify additional mechanisms underlying the robustness
of Rb phosphorylation to inhibition of CDK2 and show how long-term drug pressure unleashes
the plasticity of CDKs. Since our findings are likely to be broadly applicable beyond CDK2
inhibitors, our proposed work will fill long-standing gaps in our understanding of how the cell cycle
is wired for success in the face of perturbations.

Public health relevance
Project Narrative The mammalian cell cycle is commonly conceived as a hard-wired pathway, but emerging work indicates that the cell cycle is much more plastic than is generally believed, with multiple routes to cell division under different conditions. The proposed project uses single-cell time-lapse microscopy and cell tracking to determine how cells are able to rapidly adapt to inhibition of a key cell-cycle regulator called CDK2. The proposed work will reveal how the cell cycle is wired for success even in the face of perturbations, which may identify ways to improve the therapeutic efficacy of targeted cell-cycle inhibitors to treat human disease.